REGULATION OF TRANSCRIPTION FACTORS AND GENE CLONING IN SEIZURE PARADIGMS

Systemic administration of kainate (KA) stimulates glutamate receptors and renders animals to undergo robust seizures. This neuronal stimulation has both short-term and long-term effects on the gene expression of several transcription factors. Both CREB and AP-1 transcription factors play an important role in short-term modulation of most genes during seizures and neuronal damages. The AP-1 transcription complex composes of c-fos and fos-related antigens (FRA) and three jun proteins. It binds to the promoter regions of other genes and regulates their expression. We have found that the 35-37 kDa FRA proteins are the main forms of FRA proteins in the brain which expressed at least 5 months after one systemic injection of KA. Either Jun D or c-Jun is also detected in AP-1 DNA binding complex suggest that the FRA proteins expressed long-term changes for cellular adaptation in response to chronic or permanent changes. Genes related to neuronal plasticity may be targets for long-term FRA- containing AP-1 complexes. Regulation of proenkephalin transcription at ENKCRE 2 element via CREB/AP-1 transcription factors occurs by several second messenger systems. Flanking sites, AP-2 and ENKCRE 1 act indirectly to elevate pENK transcription. The 6-hydroxydopamine lesion at nigra region also increased the expression of 35-37 kDa protein at damaged side of striatum. Our first effort to clone 35-37 kDa transcript factor genes resulted in a M13 gene which codes a 63 kDa protein containing a leucine ZIP and a glutamine repeat in its deduced peptide sequence. However, the gene structure and function of the 35-37 kDa protein are not clear. Further work is necessary to clone and characterize this transcription factor.